Regulation and Interactions of the p53 Family

Project 1: Roles and Regulation of Mutant p53 and ANp63 in Breast Cancer Cells Carol Prives, Ph.D. Increasing evidence supports the likelihood that, in stark contrast to wild-type p53, tumor-derived mutant forms of p53 play roles in fostering tumor development, invasion and metastasis. To gain insight into the mechanism by which mutant p53 may play a role in breast cancer we adopted the

Public health relevance
Both mutant forms of p53 and the AN forms of p63 have been implicated in breast and bladder cancer, two of the major forms of human cancer. The goal of this program is to determine the mechanisms by which mutant p53 and DeltaNp63 regulate novel pathways discovered under the auspices of this program that are involved in these and other forms of cancer. The experiments we propose in many cases are derived from and dependent on inter-program collaborations.